Development of Programmable Nanobodies for Multi-functionalized Biologics

PROJECT SUMMARY
Antibody Drug Conjugates (ADCs) have been developed to deliver cytotoxic payloads (CTPs) to patients, yet their efficacy
is limited by serum instability, low tissue/tumor penetration, low cell internalization, and immunogenicity. Unstable linkers
further impair the utility of ADCs leading to off-target toxicities, non-specific CTP conjugations and heterogeneity of Drug
Antibody Ratios (DARs). Clinical trials have highlighted the diminished bioactivity of ADCs resulting from conjugations
at natural residues critical to epitope binding or structural integrity, yielding only 11 FDA approved ADC therapeutics.
Notably, two ADCs, Myolotarg (re-approved) and Blenrep were withdrawn from FDA approval due to safety concerns.
Nanobodies (Nbs), derived from heavy chain camelid antibodies, have enhanced therapeutic properties due to their small
size (~15 KDa vs. 150 KDa for Abs), and convex paratopes, which enable binding to unique epitopes inaccessible to Abs,
and improved intra-cellular delivery of CTPs yielding more efficacious therapeutics. Nevertheless, the small size of Nbs is
a double-edged sword limiting their utility with short half-lives (1-2 hours), necessitating frequent dosing and unfavorable
peak-valley pharmacokinetics with dose-limiting toxicities. Current strategies to extend their half-life (e.g., fusion to
albumin) create bulky molecules impairing tumor penetration. Anti- polyethylene glycol (PEG)-antibodies have similarly
limited clinical efficacy of therapeutics with notable recent failures of pegilodecakin (PEG-IL-10), toxicity from Doxil
(PEG-Doxurubicin) and reduced therapeutic efficacy of Oncaspar (PEG-asparginase). Pearl Bio’s innovative synthetic
biology platform can overcome these challenges by combining Genomically Recoded Organisms and orthogonal translation
systems to produce Nbs with 1-10 synthetic amino acids (sAAs) for precise tuning of therapeutic properties: (i) lipidation
for half-life tunability, (ii) tunable fluorescence-tagging for tumor detection and (iii) tunable DAR-specific CTP conjugation
with predictable homogenous products for enhanced tumor cytotoxicity. Our technology further enables multi-site encoding
of 2+ distinct sAAs within one Nb, enabling multi-functionalization and combination of these properties without
compromising tumor penetration or triggering immunogenicity. Building upon our prior work on anti-EGFR Nb (a target
validated for primary tumors and metastases) and EgA1, we will demonstrate multi-site sAA incorporation, lipidation and
CTP conjugation. Specifically, we will (1) demonstrate expression of engineered EgA1 Nb encoded with multiple sAAs,
(2) show precise conjugation of EgA1 with fluorophores, lipidated moieties, and cytotoxic payloads at sites of sAA
incorporation and (3) characterize tumor-cell targeted EgA1 nanobodies functionalized with lipids, fluorophores, and
cytotoxic payloads for tumor cell-binding, detection, and cytotoxicity. Phase 2 animal studies would be used to validate
these designs. This project is poised to establish Pearl’s platform as foundational technology for producing novel multi-
functionalized Nb biologics across diverse disease indications.

Public health relevance
PROJECT NARRATIVE Antibody Drug Conjugates (ADCs) effectively target and kill diseased cells, yet suffer from low efficacy and toxicity, low tissue/tumor penetration, low cell internalization, heterogenous Drug Antibody Ratios (DARs) and off-target drug effects whereas nanobodies exhibit enhanced tumor penetration and access to unique epitopes, yet are limited therapeutically by short half-lives with unfavorable “peak-and-valley” pharmacokinetic profiles. To address these challenges, Pearl Bio has developed a proprietary technology platform to enable precise, multi-site incorporation of 2+ distinct synthetic amino acids to design tunable, multi-functionalized next-generation biologics. In this project, we will generate multi-functionalized nanobodies to precisely tune therapeutic properties: (i) lipidation for half-life tunability, (ii) tunable fluorescence-tagging for tumor detection and (iii) tunable Drug Antibody Ratio (DAR) for CTP conjugation with predictable homogenous products for enhanced tumor cytotoxicity.